Ion Channels in Synaptic and Neural Circuit Physiology Course (2024-2028)

ABSTRACT
Ion channels are the fundamental building blocks determining cellular activity and in particular neuronal
excitability. The most elementary processes in the nervous system, such as action potential firing and synaptic
transmission, depend on their function. Coordinated activation of distinct types of ion channels enables
information transfer through complex circuits and neural networks. Addressing the need for intensive research
training in this field, Cold Spring Harbor Laboratory will offer the annual three-week course on Ion Channels in
Synaptic & Neural Circuit Physiology, as part of its postgraduate summer training program in neurobiology
(2024-2028).
The primary goal of this course is to demonstrate, through lectures and laboratory work, the different
properties of ion channels that enable neurons to perform unique physiological functions in a variety of neural
systems. The course focuses on: voltage- and ligand-gated ion channels at central and peripheral synapses;
synaptic integration and plasticity; neural circuit function in vitro and in vivo; and optogenetic strategies for circuit
manipulation. The laboratory component of the course introduces students to electrophysiological approaches
for the study of ion channels in their native environments. The course provides trainees with hands-on experience
in using patch-clamp electrophysiology to examine single channel activity in cultured cells, ion channel
biophysics in acutely dissociated neurons, action potential firing and synaptic integration, plasticity and circuit
dynamics in acute brain slices and in vivo. Different types of recordings will be used (e.g. cell-attached, whole-
cell dendritic and somatic patch, voltage- and current-clamp modes) and the advantages and limitations of each
method will be discussed in relation to specific scientific questions. The course will also provide practical
experience in cellular and circuit manipulation techniques (i.e. pharmacological, electrophysiological and
optogenetic) both in vitro and in vivo.
The lead instructors are chosen on the basis of their training, contributions to and knowledge of the field.
In turn, they invite lecturers who have made significant contributions in their fields to give up-to-the-minute reports
on the underlying technology and their current research. The trainees are chosen by the course faculty from
larger pools of applicants and range from graduate students to senior investigators. This intensive research
training program enrolls a diverse cadre of researchers who can immediately transfer techniques and concepts
learned during the course to their own research projects and interests. The faculty are encouraged to present
relevant methodological approaches in the broader context of brain function and mental health research. Their
presence is not limited to the classroom: each speaker spends a significant amount of time in the laboratory to
provide a unique learning opportunity for the attendees of the course. Methods and concepts taught in the course
are disseminated to the wider research community through the publication of laboratory manuals and online
resources.

Public health relevance
PROJECT NARRATIVE Fundamental advances in our understanding of the normal function of the human brain, and how this understanding can be used to combat brain disorders, will increasingly depend on researchers equipped with multidisciplinary technical expertise. This grant supports an advanced hands-on three-week summer course which provides a forum for in-depth evaluation of the emerging and converging research efforts linking ion channel biology, synaptic and circuit function to human brain physiology and disease. The course communicates fundamental concepts and cutting-edge experimental approaches to a select cadre of graduate and postgraduate trainees, who will immediately apply what they learn to their own areas of neurobiological research. This highly intensive course helps to embed the trainees in a motivated and collaborative network of like-minded scientists who are working to understand the fundamental operating principles of the central nervous system and the etiology of neurological disorders.